Communication of genomic information in clinical, community, and digital contexts

In the clinical context, my colleagues and I are examining the influence of the provider's apparent weight on potential patients' reaction to the weight-related genomic information she provides, as well as establishing approaches to reduce negative attitudes toward providers with larger bodies who provide information about genomics and weight. One study has been published, and two more are IRB approved and in the pipeline.

Colleagues and I have also collected data for a study examining the influence of patients' presentation with direct-to-consumer-type genomic information at their clinical visit. Data from several medical students has been collected and presented; one paper is published, others are under review and in-progress. We have planned and begun executing a follow-up study to examine how patient race and weight status influence the use of polygenic risk scores for diabetes in a clinical context among medical residents.

We are also continuing to conduct analysis on a project that assesses genetic attributions, their connection with diabetes understanding, stigma, and health outcomes in the context of diabetes. Five papers from the project are published and another is in the pipeline A follow-up analysis of children with type 1 and type 2 diabetes and their parents is ongoing. These studies have also influenced two more online surveys investigating stereotypes and beliefs related to dietary habits and weight, as well as one exploring public reaction to use of glucagon-like peptide 1 agonist medications for weight management. Data have been collected during this reporting year and analysis is in progress.